Immunologic and Predictive Features of MIS-C

The novel SARS coronavirus (SARS-CoV-2) causes the severe pneumonia-like coronavirus
disease (COVID-19). SARS-CoV-2 infected over 170 million individuals and has claimed over
3.5 million lives worldwide to date. If otherwise healthy, children were thought to be largely
spared from SARS-CoV-2 disease. However, in areas of high SARS-CoV-2 infection rates,
some children started presenting to pediatric critical care units 4-6 weeks following SARS-CoV-
2 infection with Kawasaki-like disease. Clinically, we now know that this is a distinct disease,
which was recently termed - multisystem inflammatory syndrome in children (MIS-C). While the
characteristic clinical features of MIS-C are becoming clear, the pathophysiology remains
unknown. Here we propose to evaluate three independent cohorts of MIS-C during acute and
convalescent phases of disease at clinical, genetic and immunologic levels using the latest
technology. We will not only perform systemic immunological mapping of MIS-C as compared to
controls, but also utilize machine learning algorithms to delineate how best to predict, diagnose
and outcome stratify MIS-C. We anticipate discovering immunologic and genetic features which
can aid us in assessing risks of MIS-C development, diagnosis and prognosis. In summary, our
systematic analysis and computational modeling of the clinical and immune features of MIS-C
will not only help illuminate the pathogenesis of this syndrome, but will also provide us with
actionable biomarkers for disease risk, diagnosis and progression.

Public health relevance
Multisystem inflammatory syndrome in children (MIS-C) is a disease caused by SARS-CoV-2 virus. Clinically it manifests 4-6 weeks after initial SARS-CoV-2 infection. The pathophysiological determinants are largely unknown, as is the ability to assess the relative risk of disease development, disease diagnosis and prognosis.